Alzheimer Disease Research Center

Overall Abstract:
The University of Pittsburgh Alzheimer’s Disease Research Center (PITT-ADRC) has shown
a clear scientific evolution over the past four decades. Since our inception, we have advanced the areas of ADRD
neuropsychiatry, genetics, natural history of AD, validation of clinical criteria, and clinico-pathological
correlations. Further, we have pioneered the development of both fluid and imaging biomarkers for the
development of AD pathology, which have transformed AD research. We have used a multidisciplinary approach
to better understand the transition from normal cognition to dementia, have explored the biology of AD with
psychosis, and have made and contributed to new insights in genetics. These achievements and investment in
junior investigators have allowed the PITT-ADRC to develop areas of excellence, which form the foundation of
our Center. These are reflected in our cores, and most notably in the number of large and diverse studies we
support in these areas, locally, nationally, and internationally.
The PITT-ADRC is committed to remain at the forefront of scientific efforts to understand the pathological
processes involved in the etiology of AD and structural and social determinants of health that modify those
pathological processes, making the PITT-ADRC a center that works from “Neighborhoods to Neurons”. Along
with this innovative research conducted by the PITT-ADRC, we are dedicated to developing strong training
programs to promote the careers of young investigators and to create strong ties with the community through a
variety of partnership programs, with special emphasis on groups historically excluded from research.
The PITT-ADRC is highly committed to leverage the strengths of the network of Centers to provide large
numbers of samples and standardized clinical data collection from our participants. The PITT-ADRC has
modernized our methodology to improve the accessibility of our database to researchers, and it has been a key
player in multiple studies that advanced the understanding of ADRD. Therefore, we provide an excellent
environment that enhances cutting-edge research by bringing together a multidisciplinary team of investigators
to study AD and other dementias, and to improve health care delivery.
The methodology proposed in this application will lead us to the creation of a unique and well-characterized
cohort of participants across the clinical spectrum of cognitive disorders assessed with state of the art clinical
and biomarker methods. This will allow us to test multiple scientific hypotheses and to examine the short- and
long-term public health outcomes of the pathophysiology of cognitive disorders in the adult.
The PITT-ADRC will be at the center of the new era of AD research that will require a wealth of clinical and
biological data, highly sophisticated fluid and imaging biomarker methodologies, close inter-relationship among
centers and institutions, creation and optimization of human resources, and enhanced communication with
patients and families.

Public health relevance
Overall Narrative The principal goal of the University of Pittsburgh Alzheimer’s Disease Research Center (PITT-ADRC) is to perform and promote research that increases our understanding of the etiology and pathogenesis of Alzheimer’s disease (AD) and related dementias and factors that impact risk and resilience of those disorders in order to ultimately advance the goal of development and implementation of preventive therapies. The PITT-ADRC provides the infrastructure to investigate the mechanisms underlying cognitive and behavioral symptoms, and to develop strategies for effective early diagnoses and treatments of AD. We will accomplish this goal with our own research, involving investigators at the University of Pittsburgh and nearby institutions in clinical and basic research, and with collaborations with other national and international centers of excellence, in an environment that supports innovative research and enhances training and educational opportunities for patients, caregivers, students, scientists and clinicians.